The Identification of Modifiable Emergency Department and Sleep Factors Contributing to Psychological and Cardiovascular Risk in Clinicians

Emergency department (ED) overcrowding was declared a “crisis” by the Institute of Medicine 10 years ago,
and EDs have become more crowded since. Patients treated in overcrowded EDs are at increased risk for
subsequent cardiovascular disease (CVD) and psychiatric disorder, largely due to increases in patients’
psychological stress during their acute care stay. While the association of ED stressors with patient CVD and
psychological outcomes is established, little work has explored the impact of ED environmental factors on the
nurses and doctors who spend years exposed to stressful and frequently overcrowded EDs—often after poor
sleep due to shift-work. This study will test whether modifiable ED factors and/or short sleep increase
ambulatory blood pressure (ABP) and psychological risk in ED clinicians
Whereas 45% of the 1 million physicians in the U.S. report symptoms of burnout, an astonishing 70% of ED
providers report burnout symptoms (i.e., emotional exhaustion, depersonalization, and reduced personal
accomplishment). There is evidence that aspects of acute care work (crowding, acute and chronic stress, shift
work) may contribute to burnout risk, which is related to worse patient care and more medical errors, and is
also an independent risk factor for CVD. Burnout is associated with 37% increased risk for coronary heart
disease (CHD) events, independent of age, body mass index, smoking, and lipid levels. Proposed physiological
mechanisms for the association of burnout with CVD include autonomic dysregulation and increased blood
pressure. Similarly, recent meta-analyses have shown short sleep (<6 hours) is associated with incident CHD
risk (RR=1.26), likely through similar pathways. Circadian misalignment, another consequence of shift work
common in ED providers, also increases CVD risk.
We will test the influence of ED factors, sleep, and circadian misalignment on ABP (a primary marker of CVD
risk) and burnout in an innovative study design, leveraging our expertise in ED research, behavioral cardiology,
and sleep. We will prospectively follow a cohort of ED physicians and nurses for 3 years, testing the hypothesis
that ED work factors (e.g. ED overcrowding, short sleep, and circadian misalignment due to shift work),
increase burnout and contribute to increased ABP. We will continually capture ED data on patient volume,
acuity, and staffing. Annually, participants will complete a 2-week burst, monitoring sleep duration, circadian
misalignment, and work-related stress. During each burst, we will assess burnout, job strain, and 24-hour ABP.
This design will allow us to: 1) evaluate the short-term contribution of ED crowding, circadian misalignment,
and short sleep to acute changes in ABP and psychological risk 2) characterize the relationship of cumulative
ED stress exposures and sleep impairment to 3-year progression of CVD and psychological risk.

Public health relevance
Emergency department (ED) overcrowding and related factors during a patient’s stay increase their risk for cardiovascular disease (CVD) events and subsequent PTSD. The purpose of this research is to test whether modifiable ED factors increase CVD and psychological (burnout) risk in the millions of ED clinicians worldwide who are exposed to those same risk factors for years. If our hypotheses are supported, this research may motivate changes to EDs that offset CVD and psychological risk in clinicians, and may improve patient outcomes.